MOSAIC: Data Integration and Computation Core

SUMMARY: DATA INTEGRATION AND COMPUTATION CORE
A major challenge to any integrated, collaborative, multi-institutional effort is the centralized management and
synthesis of shared data. The Data Integration and Computation Core will be central to every part of our
Mayo/Columbia CSBC Mathematical Oncology Systems Analysis Imaging Center (MOSAIC), assimilating
diverse data types and sources. The primary mission of this Core is to provide infrastructure for data resource
management, including modeling tools and support.
The Data Integration Core will house and integrate the digital data generated by the Biospecimen Core while
providing a central resource for modeling tools to support our CSBC and interacting with the Administration
Core for ensuring IRB compliance. We will achieve the mission of our Data Integration and Computation Core
through three specific aims. In Aim 1 we collect and process and store data across all CSBC sites. In Aim 2 we
provide and integrate reproducible bioinformatics workflows. And in Aim 3 we provide computational modeling
tools and techniques.
The Data Integration Core will provide support for both projects.
• Project 1: Targeting Glioma Tissue States will utilize the image-localized biopsy locations. They will further
utilize the stored molecular data accessed through this core making use of the provided bioinformatics.
• Project 2: Imaging the Dynamic Tissue State in Patients In Vivo will utilize the stored molecular and
imaging data along with all segmentations and generated image features. Project 2 will also make extensive
use of the mechanistic modeling and calibration support along with the bioinformatics support.

Public health relevance
NARRATIVE: DATA INTEGRATION AND COMPUTATION CORE The Data Integration and Computation Core will be central to our Mayo/Columbia CSBC Mathematical Oncology Systems Analysis Imaging Center (MOSAIC), collecting the diverse data types and sources and providing infrastructure for data resource management of the large datasets relied upon and generated through the center including those provided by the Biospecimen Core. The Data Integration and Computation Core will support both projects with its three aims: Aim 1) collect and store data across all sites, Aim 2) provide reproducible bioinformatics workflows, and Aim 3) provide computational modeling tools and techniques.